West Virginia DHHR Manufactured Food Regulatory Program and Food Protection Task Force

WV DHHR Manufactured Food Regulatory Program and Food Protection Task Force
Project Summary/Abstract
West Virginia Department of Health and Human Resources, Bureau for Public Health, Office of
Environmental Health Services is applying for the FDA’s Manufactured Food Regulatory Program
Standards Maintenance grant with the added project of the Food Protection Task Force. The grant
project is called WV DHHR Manufactured Food Regulatory Program and Food Protection Task Force.
Funds for this project will be used to maintain manufactured food program standards, train staff,
conduct compliance sampling, fund electronic inspection reporting and database programming, and
participate in efforts to find, track, and respond to foodborne illness outbreaks associated with
manufactured food.
The funds for the Food Protection Task Force will be used to facilitate two in-person meetings per year,
enhance variance policies, and foster communication and cooperation between regulators, industry,
academia, citizens, and lawmakers. Food Protection Task Force is responsible for helping local health
departments review and evaluate retail food establishment variance requests and provides
recommendations for approval. Task Force meetings are also utilized to help review proposed
legislation, policies, and procedures relating to food safety, food security, and public health.

Public health relevance
WV DHHR Manufactured Food Regulatory Program and Food Protection Task Force Project Narrative In 2019 West Virginia Department of Health and Human Resources (WV DHHR), Oﬃce of Environmental Health Services received their ﬁrst full conformance audit for the Manufactured Food Program Standards. Since then, WV DHHR has held conformance through the hybrid audit performed in 2021 and conƟnues to work to maintain conformance with the new 2022 MFRPS. WV DHHR is invested in the Manufactured Food Program Standards because it allows us to maintain a program that puts a priority on protecƟng public health through evaluaƟng and monitoring risk, by maintaining inspecƟonal standards and training, and by sharing data with partners. WV DHHR is working to maintain and advance our framework for mutual reliance by ensuring our staﬀ are trained according to Standard 2. As an example, WV DHHR has one inspector fully qualiﬁed to conduct process controls inspecƟons, acidiﬁed inspecƟons, Juice HACCP, and low acid canned food inspecƟons, and plans to have a second trained in all these areas prior to the conclusion of 2025. WV DHHR works with FDA to conduct work planning for the FDA contract and shares noncontract state inspecƟon data with the FDA Liaison. Our standards require the program to assess areas of weakness and idenƟfy gaps in standards on a rouƟne basis and at a minimum annually. WV DHHR MFRPS Self-Assessment has idenƟﬁed areas for improvement in the past that resulted in working to add ﬁeld staﬀ to the manufactured food program speciﬁcally. It has idenƟﬁed areas that were weak regarding policy, like adding informaƟon about when samples could be released for validaƟon tesƟng and who could request their release. WV DHHR has also adopted 21 CFR 117 by reference as part of our Food Manufacturing FaciliƟes Rule W.Va. 64 CSR 43 in 2022. This change, along with modeling our standards based on the naƟonal program, helps reduce foodborne illness risks by allowing WV DHHR to focus on the hazards that cause illnesses during inspecƟons. WV DHHR has also maintained a Food ProtecƟon Task Force for as long as the organizaƟon has been enrolled in MFRPS and VNRFRPS. Our Task Force has maintained meeƟngs during the pandemic by meeƟng virtually and returned to hosƟng in-person in November of 2022. Moving forward the Task Force will host two in-person meeƟngs. One to set projects for educaƟon and goals speciﬁcally and the other will focus on updaƟng missions, vision, and governance. The Task Force will conƟnue to uƟlize virtual meeƟng space to conduct business between in-person meeƟngs for things like commiƩees and variance review. Our Task Force is instrumental in garnering input and feedback relaƟng to draŌing legislaƟon, creaƟng policies and procedures, providing guidance for variance reviews, and serving to communicate updates to consƟtuents and partner organizaƟons. The Task Force membership consists of local health department inspectors, state agency representaƟves (DHHR, Department of Agriculture, Department of EducaƟon), FDA, Food Manufacturers, Restaurants, Grocers, Academia, and ciƟzens.